A new pathogenic mechanism for diabetic retinopathy

DESCRIPTION (provided by applicant): Accumulating evidence suggest that diabetic retinopathy (DR) is a chronic inflammatory disorder. In the prior grant period, we have successfully established that aberrant activation of the canonical Wnt pathway in the retina plays a key pathogenic role in retinal inflammation and neovascularization (NV) in DR. This project represents a logical extension of our previous studies and aims to elucidate the mechanism responsible for the Wnt pathway over-activation in DR. Peroxisome proliferator-activated receptor-α (PPARα) is a hormone-activated receptor and transcription factor. Two independent clinical studies reported surprise findings that oral administration of fenofibrate, a small molecule PPARα agonist, confers robust therapeutic effects on DR in type 2 diabetic patients. However, the mechanism for this beneficial effect on DR has not been elucidated, and the function of PPARα in the retina is unknown. Recently, we have the following finding implicating PPARα in DR: 1) PPARα is expressed in the retina. 2) PPARα expression is down-regulated in the retinas of both type 1 and type 2 diabetic models. 3) Fenofibrate ameliorates retinal inflammation and vascular leakage in DR models. 4) Fenofibrate inhibits Wnt signaling and down-regulates Wnt target genes induced by diabetes and by Wnt ligands. 5) Over-expression of PPARα alone suppressed Wnt signaling. 6) PPARα knockout (KO) abolishes the effects of fenofibrate on diabetes-induced retinal vascular leakage. Based on these results, we hypothesize that PPARα inhibits Wnt signaling and inflammation in the retina, and that the decreased PPARα expression in the diabetic retina plays an important pathogenic role in DR. To test this hypothesis, we propose the following studies: 1) We will first establish the role of diabetes-induced down-regulation of PPARα in retinal inflammation and vascular leakage in DR. We will induce diabetes in PPARα-/- mice and determine if PPARα KO exacerbates DR. Diabetic PPARα-/- mice will be treated with fenofibrate to determine if lack of PPARα abolishes the therapeutic effect of fenofibrate on DR. We will also determine if over-expression of PPARα in the retina of diabetic rats ameliorates DR. 2) We will test the hypothesis that decreased PPARα expression in diabetic retina is responsible for the aberrant activation of Wnt signaling in the retina. Specifically, we will investigate if PPARα KO exacerbates the diabetes-induced Wnt pathway activation in the retina. We will also elucidate the mechanism by which PPARα down-regulates the Wnt pathway. 3) We will define the mechanism responsible for diabetes-induced down- regulation of PPARα in the retina. These studies will define novel interactions between PPARα and Wnt signaling, establish a novel pathogenic mechanism for retinal inflammation in DR and identify an endogenous regulator of Wnt signaling. These studies will also elucidate the mechanism for the fenofibrate's effects on DR and identify a new drug target for the treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diabetic retinopathy is a common complication of diabetes and a major cause of blindness in the working age population. This project aims to explore a novel pathogenic mechanism, i.e. the role of diabetes-induced down-regulation of PPARα in the retina in diabetic retinopathy. This project may also identify a new drug target for the development of new treatment for diabetic retinopathy. Moreover, since fenofibrate, a PPARα agonist, has been shown to have robust therapeutic effects on diabetic retinopathy in patients, this project will elucidate a mechanism for this clinically effective drug for diabetic retinopathy These studies are of clinical relevance and contribute to new drug development for diabetic retinopathy.